RAPE, RESISTANCE, AND INJURY--A FOLLOW-UP STUDY

This study is a followup to an earlier NIMH-supported project conducted in 1977 through 1979. That project evaluated ways in which women could take steps to reduce the possibility of rape or to influence the outcome of a sexual assault in other ways. Our findings varied from more traditional advice given by police on how to cope with an assaulter and suggested that more assertive responses may be in order. However, the methods of our earlier study precluded the possibility of obtaining much information on rape victims who were seriously injured. Hence, we did not obtain a total picture of all the outcomes that are possible in a rape encounter and how those outcomes relate to ways that women do or do not act and cope when faced with an assaulter. The proposed study is intended to examine the nature of sexual assault incidents which resulted in serious injury to the victim and the victim's behavior as it relates to that outcome. To accomplish this, we will interview seriously injured victims of rape in the Washington, D.C., Baltimore, and Philadelphia areas. We will then prepare a report that will integrate the findings with those from the earlier study, as well as with findings from other related studies on sexual assault prevention and prevention in other crimes (e.g., resistance against robbery).